Conduct of studies to evaluate the toxic potential of nicotine in laboratory animals for the National Toxicology Program (NTP)

The goal of this project is to evaluate the toxicity of nicotine, following exposure in drinking water. Analysis of palatability study data are in progress; 28-day and three-month studies are in the design/dose selection phase. These subchronic studies will provide valuable data on the toxicity of nicotine via drinking water. Keywords: toxicity, drinking water, nicotine